Functional consequences of high glucose culture on adoptive T cell therapies for cancer

PROJECT SUMMARY/ABSTRACT
Adoptive cell therapy (ACT) is a form of immunotherapy in which T cells are isolated from a patient, genetically
modified, expanded in vitro and then transferred back to the patient to initiate antitumor immunity. Chimeric
antigen receptor T cells (CAR-T) is a form of ACT where the T cells are modified to contain a tumor specific
receptor (CAR). CAR-T cells have demonstrated clinical success particularly in hematological malignancies,
however, efficacy in solid tumors has remained poor and many patients ultimately relapse. The in vitro expansion
step of CAR-T cell therapy is critical for generating enough cells to transfer back to the patient, but the transfer
of cells from a patient to an in vitro environment and then back to the patient requires T cells to be metabolically
flexible. Cell culture media has been well demonstrated to induce metabolic dysfunction on T cells and alter their
effector function. Healthy blood glucose is approximately 5mM, however, the in vitro expansion media contains
nearly 10x blood glucose levels to favor proliferation. Preliminary data suggests that T cells cultured in high levels
of glucose are less responsive to T cell receptor (TCR) stimulation demonstrating a reduction in IFNγ and TNFα
when stimulated with αCD3/αCD28. Additionally, adoptive transfer of tumor-specific T cells cultured in 55mM
glucose into B16F10 tumor-bearing mice demonstrate reduced tumor control compared T cells cultured in lower
glucose concentrations (11mM). Increases in both intracellular and extracellular glucose have been shown to
affect glycosylation of cellular proteins. Glycosylation is an important post-translational modification that impacts
transport, signaling and localization of proteins. Thus, we wondered if intracellular glycosylation mark, O-linked
β-N-acetylglucosamine (O-GlcNAc) would be changed following culture in higher levels of glucose. Indeed, we
see elevated proteome wide O-GlcNAc as we increase glucose in culture media. O-GlcNAc is added to serine
and threonine residues by the enzyme O-GlcNAc transferase (OGT). Given the role of serine’s and threonine’s
in phosphorylation, we assessed whether T cell signaling would be altered by exposure to high levels of glucose
in culture. We restimulated the cells using a time course to assess phosphorylation of downstream T cell signaling
intermediates. Our preliminary data suggests delayed induction and reduced maximal induction of p-Erk, p-S6
and p-Akt. Thus, we hypothesize that high levels of glucose in cell culture media alter T cell signaling
pathways by blocking critical phosphorylation sites of signaling proteins with O-GlcNAc. We will test this
hypothesize by (1) identifying what cellular proteins are differentially O-GlcNAcylated and whether inhibiting O-
GlcNAcylation restores cytokine production, antitumor immunity and T cell signaling and (2) whether these findings
translate to human models using CAR-T cells. Findings from these studies will provide mechanistic understanding of
how excess glucose in the culture media contributes to protein glycosylation and whether this is linked to decreased
effector function. We will translate these findings to CAR-T cells. The insights from this study will provide rationale for
optimizing culture media formulations to enhance patient response to adoptive cell therapies.

Public health relevance
PROJECT NARRATIVE A critical component of adoptive cell therapies for cancer treatment is the in vitro expansion step where T cells are cultured in media containing very high levels of glucose to enhance proliferation. It has been well demonstrated that the culture media used during in vitro expansion can imprint lasting effects on T cell effector function in the tumor microenvironment, yet the mechanism by which high levels of glucose in culture media alter T cell glycosylation remain understudied. This proposal aims to understand how exposure to high levels of glucose, a clinical standard in the preparation of T cell therapies, alters therapeutic T cell effector function and antitumor immunity and how these findings translate to human CAR-T cells.